Mitoquinone/mitoquinol mesylate as oral and safe Postexposure Prophylaxis for Covid-19

PROJECT SUMMARY/ABSTRACT
Current oral antivirals used against SARS-CoV-2 infection such as protease inhibitors have limitations such as
absence of anti-inflammatory effects and rebound COVID-19 after a 5-day course of outpatient antiviral
treatment. Novel antiviral therapies against SARS-CoV-2 are urgently needed that ideally also limit
inflammatory responses that contribute to morbidity from COVID-19. Reactive oxygen species (ROS) impair
cellular functions and drive pro-inflammatory signaling and pathogenesis of infections with RNA viruses like
coronavirus. Mitochondria are the main source of energy and ROS (mito-ROS). Mito-ROS are regulated by the
antioxidant Nrf2 pathway that mediates pathogenesis and tissue damage of viral infections. We showed that
MitoQ, a mitochondrial antioxidant and Nrf2 agonist, inhibits in vitro and in vivo viral replication of several
SARS-CoV-2 variants of concern (VOC) and associated inflammatory response and apoptosis in airway
epithelial cells through the Nrf2 pathway. Given that MitoQ is a diet supplement that is safe and immediately
available to humans for use as possible therapeutic, we also showed antiviral efficacy of MitoQ in humans in a
carefully designed open label clinical trial of post exposure prophylaxis (PEP) of MitoQ, compared to no MitoQ
(control group), to prevent development of SARS-CoV-2 infection after high-risk exposure to a person with
confirmed SARS-CoV-2 infection. MitoQ was well tolerated. We hypothesize that MitoQ attenuates the SARS-
CoV-2-induced aberrant mito-ROS and Nrf2 pathway in epithelial cells and ultimately tissue injury that drives
development and progression of severe COVID-19. The goal of this application is to determine if MitoQ can be
used as novel oral safe outpatient post-exposure prophylaxis treatment against development of severe
COVID-19. We propose the first proof-of concept randomized, double-blind, placebo-controlled Phase II
efficacy study (RCT) with oral MitoQ use in adults at high risk for development of COVID-19, to further
establish the safety and the efficacy of MitoQ against development of SARS-CoV-2 infection. We will include
2 treatment groups (MitoQ 20 mg daily, placebo) and we aim to recruit a total of 112 participants in total (50
per group accounting for 10% attrition). The primary outcome of efficacy will be the development of SARS-
CoV-2 infection after high-risk exposure. The primary outcome of safety will be the proportion of participants
exhibiting adverse effects of any grade. Given that attenuation of detrimental host responses that propagate
viral replication may impose a higher barrier to generation of resistant viruses, this study will directly test MitoQ
as a novel oral, safe, potent therapeutic strategy for COVID-19 against emerging SARS-CoV-2 VOCs. Our
proposal will set the foundation of larger clinical trial that will advance use of MitoQ for COVID-19 to
supplement existing treatments.

Public health relevance
RELEVANCE TO PUBLIC HEALTH There is an enormous unmet need for novel oral therapies to attenuate morbidity from SARS-CoV-2 infection. The goal of this application is to determine if MitoQ can be used as novel oral safe outpatient post-exposure prophylaxis treatment against development of severe COVID-19. This work is innovative, interdisciplinary, public health-oriented, and directly addresses the goals of this funding opportunity including clinical relevance and focus on COVID-19.